Developing Next-Generation Physiology approaches for human gut microbiome research

Project Summary
The human gut microbiome field lags behind other microbial ecology fields in its application of single cell resolved
techniques capable of revealing the function of microbes at (close to) in situ conditions. By building on my lab’s expertise
in working with sample types that are taxonomically, functionally, and structurally more complex than the gut
microbiome by most metrics, I propose to transform the human gut microbiome field by catapulting it into the era
of single cell ecophysiology investigations. Rather than growing individual members of the gut microbiome in
isolation or trying to extrapolate findings from bulk omics approaches that destroy spatial information, we will study
gut microorganisms at single cell resolution where they actually live, as members of spatially structured and
metabolically interdependent ecosystems. We will investigate the functional activity and metabolic diversity of microbes
in mucosal biopsy samples from the human gastrointestinal tract using several cutting-edge technologies that are currently
not used or are underutilized in the field. Substrate analog probing and bioorthogonal labeling, in combination with
fluorescence in situ hybridization, will be used to study which cells synthesize new DNA, proteins, lipids, or
peptidoglycan under specific physicochemical conditions. These methods will also be combined with fluorescence
activated cell sorting to separate cells that change their metabolic activity in response to substrate amendment. Sorted
cells will be sequenced via shotgun metagenomics, which will provide a direct link between the active cells’ in
situ phenotype and genotype. Non-destructive Raman microspectroscopy, in combination with stable isotope
probing, will be used to study the biochemistry and substrate utilization of specific members of the human gut
microbiome. This will allow us to test whether predictions about growth substrates generated in previous metagenomics
and cultivation driven studies are truly reflective of how these microbes live in the human gut. Last, we will develop
novel correlative microscopy approaches that will integrate information from a diversity of imaging sources to visualize
microbes, their chemical composition, and gene expression activity directly in their native orientation in the gut.
Specifically, we will employ fluorescence and electron microscopy, Raman based chemical imaging, and energy-
dispersive x-ray spectroscopy on embedded and thin-sectioned mucosal samples.

Public health relevance
The goal of this project is to develop novel activity-targeted approaches to catapult the human gut microbiome field into an era of single cell ecophysiology investigations. Specifically, mucosal biopsy samples will be analyzed by a combination of substrate analog probing, stable isotope probing, Raman microspectroscopy, and correlative microscopy approaches, which together will reveal the identity, activity, and function of gut microorganisms at individual cell resolution under close-to in situ conditions.